Understanding the neurocognitive mechanisms of alpha-band brain oscillations using concurrent EEG-fMRI recordings

PROJECT SUMMARY
Alpha oscillations, 8-12Hz fluctuations in neural signals, are robust across species, covary with states of
attention, and are impacted in multiple disorder states, and in recent years have become a candidate biomarker
of attention system efficacy, particularly in disorders of attention such as attention deficit hyperactivity disorder
(ADHD). Yet, despite this broad acceptance of alpha oscillations as an attention read-out signal, significant
questions remain regarding the mechanisms and thus interpretation of alpha oscillations. The goal of our
research is to answer the central question of whether the neurocognitive mechanisms of alpha oscillations are
strictly attentional or whether they more closely reflect other mechanisms such as local processing dynamics or
system-wide tonic alertness.
To address this question, we will record EEG and fMRI concurrently in human participants, and employ causal
models, to identify functional connectivity (3T scanning) and laminar activation (7T scanning) of visual cortex
during alpha modulations across different task contexts. We aim to test (1) if alpha increases reflect cortical
suppression or tonic alertness, (2) if alpha decreases reflect cortical enhancement or local information
flow, and, (3) if alpha modulations reflect top-down signals or if they are a passive by-product of either
cortico-cortical or thalamo-cortical drivers. The results will directly impact interpretation of alpha oscillations as a
biomarker of attention-system efficacy in ADHD and related conditions, outlining a model that can be targeted in
treatment or monitoring of attention deficits in ADHD. By accounting for variability in existing findings, this work
will also differentiate between two theoretical frameworks of alpha oscillations and speak to recent debates on
whether alpha oscillations are a correlate or a product of top-down signals.

Public health relevance
PROJECT NARRATIVE This project aims to establish whether the mechanisms of alpha-range (8-12Hz) neural oscillations, robustly observed in human visual cortex, are strictly attentional or whether they reflect other mechanisms, such as local visual dynamics or system-wide alertness. We will record EEG and fMRI concurrently in human participants, and employ causal models, to identify functional connectivity of visual cortex during alpha modulations across different task contexts. The results will drive interpretation of alpha oscillations as a biomarker of attention-system efficacy in ADHD and related conditions, refining a model that can be targeted in treatment monitoring.